Bioinformatics Section

4. ABSTRACT - Bioinformatics Section (BIS)
The Center for Precision Medicine Models (CPMM) Bioinformatics Section will meet the bioinformatics needs of
the project, building on the infrastructure established during the first stage. To address the increasing use of
whole genome sequencing (WGS), we will extend variant annotation and prioritization to also include non-coding
gene regulatory variants and provide informatic methods and tools for multi-omic profiling of variant effects in
embryonic and adult mice. To improve CPMM efficiency, we will extend the Submission Tracking System by a
collaborative Data Sharing Portal and upgrade the Project Management System and LIMS. We will also extend
the CPMM Linked Data Hub (LDH) with a new AI-based literature mining pipeline based on the Retrieval-
Augmented Generation (RAG) strategy, co-developed with ClinGen, that will identify mentions of submitted
variants in literature and automate extraction of information relevant for variant evaluation and modeling. We will
additionally implement a patient omics re-analysis pipeline to help resolve a fraction of pathogenic variants
through patient omic data alone, without any animal modeling. While the interpretation of potentially pathogenic
non-coding gene regulatory variants is much less established than interpretation of coding variants, efforts are
underway in the clinical community to develop standards for evaluating their pathogenicity in clinical contexts.
To facilitate such variant assessment and modeling, we will collate relevant epigenomic and gene regulatory
information in human and mouse. Several CPMM submissions involve modeling congenital anomalies, early-
onset phenotypes likely to cause perinatal lethality in mouse, or studies of in utero therapeutics, highlighting the
need for embryo phenotyping capabilities. Therefore, we will evaluate transcriptomics and metabolomics data to
characterize embryonic and adult phenotypic characteristics resulting from modeling perturbations. In summary,
to increase the volume and quality of variant information produced by CPMM the Bioinformatics Section will
implement processes and upgrade infrastructure to improve interactions with users, increase Center throughput,
and better coordinate with other centers. Working closely with the Disease Modeling Unit and the Preclinical/Co-
Clinical Section, we will develop resources to support variant assessment and modeling for both coding and
regulatory variants. Given that almost half of CPMM submissions involve modeling of genetic variants that cause
perinatal lethality in mice, we will also implement computational methods to identify multi-omic footprints of
pathogenic variants of embryonic and adult mice.
1